Mechanisms of alcohol and menthol dependent pharmaco-neurological interactions with arecoline, an addictive and toxic areca (betel) nut xenobiotic

PROJECT SUMMARY/ABSTRACT
Psychoactive substances provide temporary feelings of euphoria, but also elicit multifold harm to the human
body. Areca (betel) nut is the 4th most common abused substance worldwide, only behind alcohol, caffeine,
and nicotine. Though AN chewing is traditionally recognized abroad, emerging evidence demonstrates use
within migrant and refugee communities in the US. Despite global popularity, there is a dearth of knowledge
about how the predominant psychoactive and toxic substance in the nut, arecoline, is metabolized and the
biological consequences if its metabolism is perturbed by other substances. Ethanol is commonly co-abused
with AN, and significantly their combined ingestion is associated with greater patient harm for reasons yet to be
determined. Our supporting data demonstrate that ethanol inhibits arecoline metabolism, suggesting arecoline
accumulation will occur in the blood and brain tissue – a highly significant toxicokinetic interaction. We have
also identified that L-menthol is present in commercialized (branded) AN products sold in the US, and our
preliminary findings show menthol deters arecoline hydrolysis. Taken together, the long-term goal of this
project is to improve the health of AN substance abusers. The overall objectives in this application are to (i)
confirm human hydrolase(s) and tissue site(s) catalyzing hydrolysis of arecoline; (ii) characterize a newfound
ethanol drug interaction with arecoline; and (iii) distinguish changes in arecoline's pharmacokinetic profile and
neurobiological activity following co-ingestion with L-menthol, a substance of emerging concern in branded AN
products. The central hypothesis is that arecoline is subject to metabolic inhibition when combined with ethanol
or L-menthol leading to increased toxicity and greater CNS effects. The central hypothesis will be tested by 3
specific aims: 1) Establish the predominate contribution of human esterases and tissue sites that hydrolyze
arecoline; 2) Dissect the influence of ethanol on arecoline disposition; and 3) Elucidate the pharmaco-
neurological significance of menthol in commercialized AN products. The aims will be accomplished by an
interdisciplinary team with varied expertise in trace drug analysis, carboxylesterase drug metabolism,
biomimetic 3D organoid systems, special knock-out mouse models, and drug addiction. Male and female mice
will be used throughout the aims to assess sex as a biological variable. Ultimately after 5-years, we expect to
be the first to demonstrate arecoline is predominantly metabolized in the liver by carboxylesterase-1 (CES1),
an enzyme we anticipate catalyzes transesterification of arecoline in the presence of ethanol, forming a unique
metabolite with toxicological properties. Further, we anticipate L-menthol combined with arecoline will provoke
arecoline buildup in brain tissue and modify the neurobiological profile and psychoactivity in mice, a brand new
pharmaco-neurological interaction. Findings in conglomerate will advance insight about AN addiction, and yield
a scientific foundation for implementing strategies to lessen this psychoactive substance's toxic burden.

Public health relevance
Project Narrative The proposed research is relevant to public health because it focuses on identifying mechanisms of toxicokinetic interactions when areca (betel) nut abusers co-ingest other substances such as alcohol or menthol. This project will not only bring us closer to implementing strategies to mitigate these adverse interactions, but also enrich our understanding of areca nut addiction. Thus, the proposed research is relevant to the part of The National Institute of Drug Abuse (NIDA) mission that pertains to advancing scientific discoveries about the consequences of drug abuse.